Targeted Biomarker Panels and Pre-processing Device for the Rapid Assessment of Radiation Injury in Easily Accessible Biofluids

This proposal builds upon our metabolomics expertise in untargeted and targeted metabolomics for the
generation of highly sensitive and quantitative targeted multiplex assays. The idea behind generating such
assays for radiation assessment and radiation injury in easily accessible biofluids (urine, blood, saliva) is to
rapidly determine the extent of exposure of an individual and distinguish between the worried well and the
exposed individuals that may require medical intervention. Highly quantitative approaches will be undertaken
through liquid chromatography tandem mass spectrometry (LC-MS/MS) to quantify each already identified
radiation biomarkers in each biofluid. Such instruments are currently used routinely in clinical laboratories,
therefore maximizing the available resources for rapid evaluation of thousands of individuals during an
emergency. Based on criteria for sensitivity, high signal-to-noise ratio, low signal suppression from matrix
effects, and high fold changes compared to controls or relationships between pairs of metabolites,
biosignatures will be assembled and concentrations calculated. The combined biosignature will be developed
in a multiplex assay, effectively reducing the time between sample preparation to results. The goal is to
demonstrate that this multiplex assay method has the potential to be deployed in the case of an emergency to
a pre-determined network of clinical laboratories that can accept and rapidly process a high volume of
samples. While the ultimate goal will be for such a panel to be predictive in all cases, even a limited false
positive rate would facilitate assessment of radiation injury in a mass casualty scenario: e.g. a 1% false
positive rate would reduce the number of individuals needing further evaluation by 100-fold. Additionally, this
assay will be flexible as it could be enriched with biomarkers for specificity and radiation quality. This
application also combines the engineering experience and capabilities of our collaborators to further develop
pre-processing devices with the intention of stabilizing the sample during transport to a clinical facility. The
materials to be fabricated will also aim to enrich the biosignature for the radiation-related metabolites and
extract them effectively from small amounts of a biofluid (urine, serum, whole blood, saliva), transported as a
stable dry membrane. Assembly of such materials in a 96 well plate will further decrease the sample
preparation time and minimize human error associated with sample preparation. Our unique approach to
combine LC-MS/MS applications with pre-processing materials will aim to move this technology from the
feasibility stage to technology development, satisfying the needs for rapid methods for radiation injury
assessment.

Public health relevance
Radiation metabolomics is a well-established field in biomarker discovery and in assessing changes associated with metabolic perturbations, whether in tissues or biofluids. We have developed a rich database of radiation biomarkers in urine, blood, and saliva and we now plan to develop multiplex assays that are highly quantitative and can serve as the first step towards a deployable assay using commercially based instruments. Additionally, we will further develop membrane-based technologies that will aim to eliminate the pre-processing steps, thereby jump-starting the sample processing step and enrichment for specific classes of metabolites and stabilizing the biosignature during transport.